Live Imaging of Skin Regeneration

Summary
Tissue homeostasis and regeneration are sustained by stem cells, which must both continually renew
themselves while keeping up with the demand of new differentiated cell types to replace those lost throughout
the life of a tissue. Failure to properly balance these two processes can lead to a host of problems, including
impaired organ function and tissue repair, as well as tissue overgrowth and cancer. Understanding the basic
mechanisms underlying this delicate equilibrium of stem cell self-renewal and differentiation is an essential
step in preventing and treating a wide range of diseases.
We still lack fundamental knowledge of how these stem cell behaviors are regulated during tissue
regeneration in an intact, living tissue. The goal of this proposal is to understand how individual stem cell
decisions are made within the stem cell population so that collectively their behaviors remain balanced within
the broader context of the tissue, while preserving both structure and function. The challenge in addressing
these fundamental questions lies in the inability to study these dynamic cellular processes in an intact
mammal. To this end, my laboratory has established an in vivo strategy to directly visualize and manipulate
stem cells in the skin epithelium of live mice, taking advantage of its unique accessibility, continuous
regeneration throughout its lifetime, and the presence of multiple stem cell populations that use distinct
regenerative strategies.
Using a novel, non-invasive two-photon imaging approach, we are finally able to follow stem cells as
they self-renew and differentiate over time. In order to understand how stem cell behaviors are balanced , and
determine how a stem cell's shape, position and molecular character affect cell fate decisions and the overall
regenerative ability of the tissue, we have combined our imaging approach with newly developed methods that
allow us to manipulate each cell and their behavior individually in a live mouse. This unique combination of
expertise, knowledge, and development of novel in vivo imaging tools has allowed us to first, define aspects of
tissue regeneration that were previously inaccessible, revealing unexpected principles of stem cells and
second, to understand the complex interplay between stem cell behaviors that fuel tissue regeneration over
time.
The goal of this proposal is to advance our understanding of how stem cell behaviors are balanced to
sustain tissue regeneration over time through the use of an integrated approach of cutting edge imaging
technology, genetic manipulation and cell biology. Given that many aspects of stem cell biology have been
shown to be widely conserved in other organs, our findings will be relevant to other tissues as well, and will
provide an important foundation for the treatment of a range of diseases.

Public health relevance
Narrative Research into stem cell holds tremendous promise to cure disease. The proposed research will utilize novel strategies that will enable us to capture aspects of biology heretofore inaccessible, and that will have broad implications for understanding mechanisms that govern stem cells during normal regeneration and disease.